Highly multiplexed circuit mapping using barcoded rabies viruses and in situ sequencing.

ABSTRACT
Understanding the function of neural circuits requires thorough investigation of two circuit
elements: cell types and connectivity. The combination of axonal tracing with high-throughput
DNA sequencing of genetically barcoded neurons has enabled the simultaneous characterization
of anatomical and molecular identities of neurons and their projection fields. However, no high-
throughput tools currently exist that allow us to map connections between presynaptic and
postsynaptic neurons while identifying the cell types of mapped neurons.
Here we propose to apply a family of novel sequencing-based approaches using barcoded rabies
viruses to achieve two main goals: first, to allow characterization of projection neurons
everywhere in the brain that project to multiple target regions; and second, to allow simultaneous
mapping of the inputs to transcriptomically-distinct subtypes of neurons. We will combine our well-
established single-cell RNA-seq (scRNA-seq) pipeline with retrograde labeling (Retro-seq) for
rabies barcode detection in order to conduct highly multiplexed cell type characterization of
neurons projecting to each of the many target areas across the brain. Furthermore, we will adapt
our barcoded anatomy resolved by sequencing (BARseq) pipeline to characterize the spatial
distribution and cell types of those projection neurons (Retro-BARseq). We will further establish
the methodology to investigate the anatomical and transcriptomic features of neural circuitry
revealed by rabies-based retrograde trans-synaptic circuit tracing using scRNA-seq/BARseq
(TransR-seq and TransR-BARseq). Finally, we will strive to reach single-neuron-level
connectome tracing and sequencing in wild-type mice by applying the optimized barcoded rabies
viruses to achieve unique barcoding of individual neurons.
Success of the project will result in a set of high-throughput, high-resolution methods for
sequencing the connectome by combining barcoded rabies viruses with omics, therefore
revealing both the connectivity and transcriptomic identities of neurons within a given neural
circuit. These techniques, the majority of which should be applicable to any mammalian species,
will provide orders of magnitude increases in both throughput and resolution of neuronal circuit
analysis, with a transformative impact on many branches of neuroscience.

Public health relevance
PROJECT NARRATIVE Understanding the function of neural circuits requires thorough investigation of two circuit elements: cell types and connectivity. We propose to develop novel sequencing-based approaches using genetically barcoded rabies viruses for “sequencing the connectome”, revealing both the connectivity and gene expression of neurons within a given neural circuit at the resolution of genetically-defined cell types. Success of the project will greatly increase the throughput and resolution of neural circuit mapping in mammalian nervous systems, allowing the construction of highly-detailed projection and connectivity datasets that will inform and increase the power of experiments conducted by many neuroscientific laboratories worldwide.